Architecture, dynamics and regulation of erythrocyte ankyrin-1 complexes

PROJECT SUMMARY/ABSTRACT: Ankyrin-1-mediated membrane protein clustering and crosslinking to the
spectrin-actin cytoskeleton is critical to maintaining the shape and mechanical properties of the erythrocyte
membrane, and disruption of the ankyrin-1 complex is a proximal cause of several hereditary anemias
characterized by alterations in erythrocyte shape and stability, the most frequent of which is hereditary
spherocytosis (HS). The mechanistic basis of ankyrin-mediated membrane protein clustering is not well
understood, in erythrocytes or any other tissue. Understanding how ankyrin-1 clusters functionally important
membrane proteins such as the band 3 anion exchanger and crosslinks them to the spectrin-actin skeleton, will
inform our understanding of how ankyrins modulate membrane curvature in a physiological complex, and how
loss of specific components leads to disruption of membrane curvature in the context of inherited anemias such
as HS. We will approach this challenge of characterizing the architecture, dynamics and regulation of the human
erythrocyte ankyrin-1 complex in the context of three specific Aims. In Aim 1, we will probe the architecture and
assembly of erythrocyte ankyrin-1 complexes, with the ultimate goal of understanding their disposition in the
context of native erythrocyte membranes. We will approach this using single particle cryoelectron microscopy
(cryoEM) of purified complexes, in either detergent micelles or lipid nanodiscs, as well as applying cryoelectron
tomography (cryoET) and sub-tomogram averaging to characterize the structure, composition and conformation
of the complex in the context of native erythrocyte membrane vesicles. In Aim 2, we shift our focus to the band
3 anion exchanger, the most abundant membrane protein in the erythrocyte and a key binding partner of ankyrin-
1, which plays a key role in gas exchange across the membrane, but for which the transport mechanism is
unclear. We will characterize the inward-facing state of the transporter, both alone and in complex with ankyrin-
1, and identify functionally relevant anion binding sites using cryoEM in conjunction with molecular dynamics
simulations. Functional characterization of recombinantly expressed mutants using liposome uptake assays will
be used to validate identified anion binding sites. In Aim 3, we will investigate regulation of the band 3 anion
exchanger, and the ankyrin-1 complex, by the phosphoinositide PIP2. A PIP2 binding site has recently been
structurally identified in band 3, but the functional significance of this site is unclear. We will address this by
depleting PIP2 from both purified band 3, and the purified ankyrin-1 complex, and characterizing the effects of
PIP2 depletion on structure and function. Our research will broadly impact the field, by unraveling the structural
basis of ankyrin-mediated membrane protein clustering and modulation of membrane curvature, and provide
insights into the regulation of both processes by phosphoinositides.

Public health relevance
PROJECT NARRATIVE: Disruption of the ankyrin-1 complex by inherited mutations is a feature of several hereditary anemias, including hereditary spherocytosis (HS). In HS mutant red blood cells, the curvature of the membrane is disrupted, and cells become much more fragile, but the architecture of the ankyrin-1 complex and the mechanism by which it controls membrane curvature is poorly understood. We seek to address this by characterizing the structure and function of the ankyrin-1 complex, both purified and in the context of the human red blood cell membrane.